IGF::OT::IGF : OPTION (NINDS)PURITY SPECIFICATIONS, STORAGE AND DISTRIBUTION FOR MEDICATIONS DEVELOPMENT. JULY 9, 2017 - JULY 8, 2019. N01DA-17-8934PURPOSE: TO EXERCISE OPTION PERIOD 01, QUANTITY

IGF::OT::IGF : OPTION (NINDS)PURITY SPECIFICATIONS, STORAGE AND DISTRIBUTION FOR MEDICATIONS DEVELOPMENT. ?This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.?